The Determinants of CD8 T cell Dysfunction in Oral Cavity Squamous Cell Carcinoma

PROJECT SUMMARY
Head and neck cancer, including oral cavity squamous cell carcinoma (OCSCC), is the sixth leading cause of
cancer and a major cause of morbidity and mortality. Unfortunately, the five-year survival rate of OCSCC has
only slightly improved in the past 30 years. Recently, immune checkpoint inhibition (ICI) therapies have emerged
as a promising treatment to improve OCSCC outcomes, yet only 14-22% of OCSCC patients respond to ICI.
Thus, delineating the mechanisms of ICI resistance represents an opportunity to identify novel targets that may
increase ICI efficacy and improve OCSCC patient survival. CD8 T cells are the primary immune cell type that
kills malignant cells during ICI, and their dysfunction may contribute to ICI resistance. During the chronic
response to a tumor, CD8 T cells enter an exhausted cell state – a dysfunctional phenotype characterized by
decreased ability to lyse target cells. Expression of the transcription factor thymocyte selection-associated HMG
box (TOX) is critical for inducing CD8 T cell exhaustion and is enriched in the exhausted CD8 T cell subset within
single cell RNA-seq datasets of OCSCC patient tumor samples. The genes that are directly transcriptionally
regulated by TOX that promote CD8 T cell dysfunction and may be therapeutically targeted, however, remain
poorly defined. In addition to TOX, malignant cell signals may contribute to CD8 T cell dysfunction and ICI
resistance. We discovered a hybrid epithelial/mesenchymal (HEM) malignant cell state in OCSCC that localizes
to the tumor edge adjacent to CD8 T cells and is associated with exhaustion of these adjacent CD8 T cells. The
mechanisms of HEM cells underlying this association are not well understood. The primary hypothesis of this
proposal is that CD8 T cell dysfunction in OCSCC is driven by the direct gene targets of TOX in CD8 T cells and
by immunosuppressive contact and paracrine signaling from HEM cells. The goal of this proposal is to define
mechanisms of CD8 T cell dysfunction that may be targeted to improve ICI through the following Aims: In Aim 1,
the direct gene targets of TOX and their role in CD8 T cell dysfunction will be defined in vitro using CD8 T cells
isolated from OCSCC samples. In Aim 2, patient-derived CD8 T cells will be co-cultured with patient-matched
OCSCC tumor-derived organoids or cancer cell lines expressing a model antigen. In these co-cultures, HEM-
specific membrane and secreted proteins will be knocked-down in the malignant cells to determine their role in
suppressing CD8 T cells. The proposed research will provide mechanistic insight into CD8 T cell dysfunction in
OCSCC, thereby supporting development of new strategies to therapeutically activate CD8 T cells and improve
ICI and OCSCC outcomes. Importantly, during this fellowship, I will pursue scientific and clinical activities under
the direct mentorship of a comprehensive fellowship advisory committee composed of physician-scientists and
experts in cancer and immunology research. My proposed training will be vital to accomplishing my goal of
investigating cancer-immune interactions and maturing as an independent, academic physician-scientist.

Public health relevance
PROJECT NARRATIVE Oral cavity cancer outcomes have not significantly improved over the past 30 years. Immunotherapy is a new type of cancer treatment that uses the body’s own immune cells, such as T cells, to attack cancer, but it only works in a small number of patients for reasons that we do not understand. In this proposal, we aim to improve oral cavity cancer outcomes by determining why T cells do not kill cancer cells and discovering new ways to increase the ability of T cells to attack cancer.